American Indian Educators Projects

The NCMHD provided funds to the Division of Human Resource Development, National Science Foundation (NSF) to support the Salish Kootenai College Developing American Indian Secondary Educators Project;and the Forth Berthold Community College Mada Maagarishtauo Awa Hee Aadsa Maa Aru Maa Giguckligash Project.